Human Enteroids, Colonoids, and iPSC derived HIO's to study CFTR-relatedDisorders

PROJECT SUMMARY The unifying hypothesis to be tested in this proposal is that the mutant CFTR correcting and potentiating roles of guanylate cyclase 2C (GC-C)-agonists can restore fluid homeostasis of the gut in a subset of population with chronic constipation emanating from mutant CFTR functional deficit. We will test this hypothesis using patient derived intestinal stem cells derived from crypts (enteroids) to study fluid secretion in vitro; and the induced pluripotent stem cells (iPSCs) derived human intestinal organoids (HIOs) in mouse kidney capsule and be used as models to study fluid secretion in vivo. The proposed studies are highly significant because (i) it addresses the pathologies of several deadly human diseases by utilizing models from humans; (ii) it has clinical relevance and implications; (iii) it is a multidisciplinary project covers basic biomedical studies, assay developments, and drug discovery using personalized human stem cell cultures.

Public health relevance
PROJECT NARRATIVE Chronic constipation is one of the most common diseases, affecting from 2% to 27% of the population worldwide. In this grant application we will look at a subset of patients suffering from chronic constipation that are suspected of impaired Cystic Fibrosis Transmembrane Conductance Regulator (CFTR) function and referred to our Cystic Fibrosis Center by our gastroenterologists. Generating intestinal stem cells (enteroids and induced pluripotent stem cells) from patients with chronic constipation will allow us to study the pathological human intestine, cell development and function in general, as well as to identify potential patient- specific mutant CFTR-correctors.